TIME COURSE OF LOT UTILIZATION

The reporting pattern of reports for individual vaccine lots was used to model and estimate lot consumption. The work was begun in Spring 1994. Specific reporting patterns for 7 different vaccines were worked out by Dr. Kapit and Nate Rickels, a summer student. These reporting patterns were used to estimate times for lot consumption for the 7 different vaccines. These times estimated the time for 50%, 80%,90% consumption of vaccine lots for each type of vaccine. Actually continuous times were estimated.